Multimodal Imaging in Frontotemporal Degeneration

PROJECT SUMMARY
This is the first renewal application for a K24 award for Dr. Howard Rosen, a behavioral neurologist at the
University of California, San Francisco. Dr. Rosen’s research focuses on early recognition and longitudinal
tracking of atypical neurodegenerative diseases, in particular frontotemporal dementia (FTD). The work takes
place at the UCSF Memory and Aging Center, a large multidisciplinary group dedicated to research, care and
education in neurodegenerative diseases. In the first cycle of this project, Dr. Rosen served as a mentor for 21
individuals at various stages of training and accomplished his goals of expanding his research on familial forms
of FTD. He helped to implement new strategies for diagnosis of FTD through collaboration with the UCSF
Department of Psychiatry. Dr. Rosen also expanded the reach of his educational expertise by leading
development of the educational curriculum for a new training program called the Global Brain Health Institute,
the mission of which is to address worldwide threats to brain health through training of professionals from a
variety of disciplines. With continued K24 funding, Dr. Rosen will continue his leadership of research and
training at the MAC, focusing on improving methods for measuring change in FTD for use in clinical trials and
expanding collaboration with UCSF Psychiatry. He will improve his expertise as an investigator through
selective coursework and collaboration with expert colleagues at UCSF.

Public health relevance
PROJECT NARRATIVE This project would support continued funding for Dr. Howard Rosen, a behavioral neurologist in the Department of Neurology at the University of California, San Francisco. Dr. Rosen conducts patient-oriented research on early and accurate diagnosis and longitudinal tracking of diseases that cause dementia, in particular frontotemporal dementia. He is a committed teacher and funds from this project will allow him to continue mentoring young trainees whose goals is to pursue research in neurodegenerative disease.